Community-based air toxics monitoring during rapid environmental change in industrialized neighborhoods

In June 2019, a massive explosion at the east coast’s largest oil refinery shook buildings across South
Philadelphia.1 Residents were told to shelter-in-place while 676,000 pounds of hydrocarbons and 3,271 pounds
of deadly hydrogen fluoride (HF) washed over their neighborhood,2,3 and the city health department assured
residents that there was no evidence of a health risk.4-6 Two years later, the non-operational Philadelphia Energy
Solutions (PES) complex remains the 2nd-highest benzene-emitting refinery in the U.S..7 Despite substantial
emissions of volatile organic compounds (VOCs) during decommissioning and demolition, little data has been
made available to residents; the one local EPA Air Quality System (AQS) monitor for VOCs operates only every
6th day, and required fenceline monitoring washes out peak events in 2-week averages.8,9 Neither data source
has been updated online since March 2020.10-12
Our key goal is to collaborate with Philly Thrive
– an environmental justice organization with a primary
constituency of fenceline residents -
to design and establish a community-scale air toxics monitoring network, to
capture and report on-going exposures throughout decommissioning and reconstruction, in this vulnerable
community. Residents near refineries and petrochemical complexes are disproportionately African-American,
61% are
persons of color, and 45% live in poverty.7,15 The confluence of social stressors and pollution exposures
surrounding this site – and the model for community-based monitoring design that we are developing - has
relevance and utility for fenceline communities nationwide.
Hispanic, and of lower socioeconomic position (SEP);13,14 here, over 300,000 people live within 3 miles;
By establishing a high-density, community-scale BTEX (benzene, toluene, ethylbenzene, xylene) VOC
monitoring network, we will assess both where exposures are elevated, and when changes in source activity
and meteorology increase exposures. Throughout the planned 10-year decommissioning process – which will
include removal of 950 miles of pipe, dozens of storage tanks, and underground benzene ‘pools’19,20 - our
monitoring system will provide critical reassurance to the community when concentrations are low, and a means
for advocating for improvement when concentrations are high - with the credibility of third-party academic
scientists with an established relationship with the community. Our study will vastly improve spatial and temporal
resolution over the current sparse monitoring, towards reducing exposures, and
powerful levers towards advocating for cleaner processes.
providing critical information
We will seek further funding to maintain the system
over the 10-year decommissioning and reconstruction process. Data and land use regression (LUR) models
produced will greatly improve spatio-temporal exposure assessment for on-going and planned epidemiologic
studies. This work will provide an important model for environmental monitoring in urban communities
undergoing rapid environmental change,21,22 and directly improve studies of VOCs and health.23

Public health relevance
The non-operational Philadelphia Energy Solutions (PES) complex in South Philadelphia remains the 2nd-highest benzene-emitting refining facility in the U.S. - though, with over 300,000 people living within 3 miles, little data has been made available to residents during decommissioning or demolition. In this project, we aim to work with Philly Thrive – an environmental justice organization primarily comprised of fenceline residents - to design and establish a community-scale air toxics monitoring network, to capture and report on-going exposures throughout .7,15 By establishing a high-density, community-scale BTEX VOC monitoring network, we will vastly improve spatial and temporal resolution over the current sparse monitoring, towards cost-effectively reducing emissions, powerful policy levers towards advocating for cleaner processes, and data transparency – for critical reassurance when concentrations are low, a means for advocating for improvements when concentrations are high decommissioning and reconstruction providing critical information - and producing spatiotemporal models to support future epidemiologic analyses.